Biopsychosocial pain predictors of mobility decline in aging

Project Summary/Abstract. Mobility disability impacts approximately 30% of individuals aged 60-69, 40% of
individuals aged 70-79, and 55% of individuals age 80 or older. Emerging cross-sectional evidence suggests that
self-reported musculoskeletal pain may be one of the major drivers of age-related mobility decline. Despite this
evidence, significant knowledge gaps remain because the relationships among chronic musculoskeletal pain,
aging, mobility, psychosocial function, and the brain have not been studied longitudinally in the same older
individuals. Our prospective study design will provide novel information on the role of pain-related brain changes
as predictive factors of age-related mobility decline. The proposed work will allow us to determine whether pain as
well as brain structure and function predict mobility decline longitudinally (Aim 1) and whether brain measures
mediate the pain-mobility association prospectively (Aim 2). Findings may support the value of incorporating pain’s
impact on the brain into treatments that target mobility decline in aging. The proposed work integrates multiple
fields of study within a biopsychosocial approach to study pain and mobility in the older population.

Public health relevance
Project Narrative. In older adults with musculoskeletal pain, both joint pathology and pain have been associated with mobility decline, but the relationship between joint pathology and pain and their unique contributions to mobility decline is more complex, because pain is shaped by a combination of central and peripheral factors. The proposed study goes beyond the characterization of an individual mechanism and integrates multiple fields of study using a biopsychosocial approach to identify the factors that contribute to functional trajectories of mobility decline in aging.